Overcoming established anaphylactic hypersensitivity to peanuts

DESCRIPTION (provided by applicant): Serious food allergies are a significant health problem for both the affected individuals and in the context of public health, where general measures to prevent life-threatening exposure to allergic individuals are a major logistical challenge. Approximately 2.1% of US children are affected with peanut (PN) allergies, and PN anaphylaxis is both the primary cause of food-related deaths and accounts for 60% of all fatal/near-fatal anaphylactic reactions. Peanut allergy commonly develops early in childhood, and unlike many food allergies does not wane over time in ~80% of affected individuals. Current management is limited to strict avoidance and rescue epinephrine upon exposure. Thus the young and healthy patient population at risk, the severity of PN hypersensitivity, its rising prevalence and the publc health costs to limit accidental exposure underscores the great need for new treatment strategies. We have reasoned that targeting the immune components necessary for the anaphylactic response to PN, and then preventing their regeneration, will greatly reduce the risk of life-threatening exposures. It is clear that anaphylaxis is exquisitely dependent on PN-specific IgG and IgE antibody (Ab) titers. How these titers are sustained is poorly characterized, and we have demonstrated for the first time there are both antigen (Ag)-dependent (e.g. wane over time) and Ag-independent (persistent >12 mos) antibody titers in PN-sensitized mice that are not re-exposed to PN. This was reflected in diminished but persistent anaphylactic responses upon challenge 6-12 mos after initial sensitization. How PN-specific Ab titers persist long-term without re-exposure is unknown, but durable humoral immunity following vaccination requires continuous Ag-independent immunoglobulin production by long lived plasma cells (LLPC) that can survive for decades/lifetime in specific bone marrow (BM) niches. We have recently reported that an essential requirement for LLPC survival and long-term humoral immunity is plasma cell (PC)-intrinsic function of CD28. CD28 is predominantly characterized as the prototypic costimulatory receptor on T cells that, in conjunction with TCR signaling, results in T cell activation, enhanced function (including help necessary for B cell responses) and survival. PC also express CD28, and delivers an essential pro-survival signal to LLPC that is necessary for long-term maintenance of antigen-specific Ab titers in vivo. This raises the novel hypothesis that CD28 activation plays a central role in PN anaphylaxis by both costimulating Ag-dependent helper T cell activation during sensitization/recall responses and maintaining Ag-independent LLPC production of anti-PN IgG/IgE titers. We propose that the novel approach of targeting CD28 will eliminate established PN-specific antibody titers and prevent resensitization by tolerizing PN-specific helper T cells, leading to a significant reduction of PN hypersensitivity tht can be maintained without chronic continuing therapy. The Specific Aims are: 1). Define the role of CD28 in generating and maintaining PN-specific immune responses involved in PN anaphylaxis, 2). Determine if blocking CD28 activation overcomes established PN hypersensitivity.

Public health relevance
PUBLIC HEALTH RELEVANCE: Serious food allergies are a significant health problem for both the affected individuals and in the context of public health, where general measures to prevent life-threatening exposure to allergic individuals are a major logistical challenge. Approximately 2.1% of US children are affected with peanut (PN) allergies, and PN anaphylaxis is both the primary cause of food-related deaths and accounts for 60% of all fatal/near-fatal anaphylactic reactions. Current management is limited to strict avoidance and rescue epinephrine upon exposure. We hypothesize that activation of the CD28 receptor on T cells and antibody-producing plasma cells (PC) plays a central role in PN anaphylaxis by activating PN-specific T cells and maintaining production of anti- PN IgG/IgE antibodies. This points to a novel therapeutic approach of targeting CD28 to eliminate established PN-specific antibody titers and prevent resensitization by tolerizing PN-specific T cells, leading to a significant reduction of PN hypersensitivity that can be maintained without chronic continuing therapy. __SpecificAimsTextDelimiter__ Specific Aims . Serious food allergies are a significant health problem for both the affected individuals (typically otherwise healthy children) and in the context of public health, where general measures to prevent life-threatening exposure to allergic individuals are a major logistical challenge. The incidence of food allergy is still rising globally, with an 18% increase in prevalence among children from 1997-2007. Approximately 2.1% of US children are affected with peanut (PN) allergies, and PN anaphylaxis is both the primary cause of food-related deaths and accounts for 60% of all fatal/near-fatal anaphylactic reactions. Peanut allergy commonly develops early in childhood, and unlike many food allergies does not wane over time in ~80% of affected individuals. Current management is limited to strict avoidance (even so, inadvertent exposure occurs in 12.5% to 25% of children with peanut allergies annually) and rescue epinephrine upon exposure. Thus the young and healthy patient population at risk, the severity of PN hypersensitivity, its rising prevalence and the public health costs to limit accidental exposure underscores the great need for new treatment strategies. We have reasoned that targeting the immune components necessary for the anaphylactic response to PN, and then preventing their regeneration, will greatly reduce the risk of life-threatening exposures. It is very clear in both animal models and allergic individuals that anaphylaxis is exquisitely dependent on PN-specific IgG and IgE antibody (Ab) titers. How these titers are sustained is poorly characterized, and we have demonstrated for the first time there are both antigen (Ag)-dependent (e.g. wane over time) and Ag-independent (persistent >12 mos) antibody titers in PN-sensitized mice that are not re-exposed to PN. This was reflected in diminished but persistent anaphylactic responses upon rechallenge 6-12 mos after initial sensitization. How PN-specific Ab titers persist long-term without re-exposure is unknown, but durable humoral immunity following vaccination requires continuous Ag-independent immunoglobulin production by long lived plasma cells (LLPC) that can survive for decades/lifetime in specific bone marrow (BM) niches. We have recently reported that an essential requirement for LLPC survival and long-term humoral immunity is plasma cell (PC)-intrinsic function of CD28. CD28 is predominantly characterized as the prototypic costimulatory receptor on T cells that, in conjunction with TCR signaling, results in T cell activation, enhanced function (including help necessary for B cell responses) and survival. Conversely, blocking CD28 activation induces T cell tolerance, and in the single reported study of this approach in PN allergy found that CD28 blockade during sensitization inhibited both PN-specific T cell and Ab responses. CD28's role in humoral immunity has been almost entirely attributed to helper T cell costimulation and germinal center formation, but PC also express CD28. We have found that CD28 on PC delivers an essential pro-survival signal to LLPC that is necessary for long-term maintenance of antigen-specific IgG titers in vivo (we did not examine IgE titers). Furthermore, PC CD28 interacts with its ligands CD80 and CD86 on BM dendritic cells (DC) that are part of the pro-survival niche, and loss of CD80 or CD86 also abrogates LLPC survival and durable humoral responses. This raises the novel hypothesis that CD28 activation plays a central role in PN anaphylaxis by both costimulating Ag-dependent helper T cell activation during sensitization/recall responses and maintaining Ag-independent LLPC production of anti-PN IgG/IgE titers. Thus specific inhibitors of CD28 (e.g. CTLA4-Ig, which are already FDA approved to treat rheumatoid arthritis) may not only tolerize the PN-specific helper T cells necessary for the B cell response, but also directly target the LLPC producing the existing PN-specific IgG/IgE titers necessary for the anaphylactic response. We propose that the novel approach of targeting CD28 will eliminate established PN-specific antibody titers and prevent resensitization by tolerizing PN-specific helper T cells, leading to a significant reduction of PN hypersensitivity that can be maintained without chronic continuing therapy. The work detailed in this proposal is preclinical proof-of- concept, but there is a clear translational path given that agents that block CD28 activation are already in clinical use. The Specific Aims are: Aim 1. Define the role of CD28 in generating and maintaining PN-specific immune responses involved in PN anaphylaxis. Aim 2. Determine if blocking CD28 activation overcomes established PN hypersensitivity.